Tennessee Valley Cooperative Human Tissue Network

{\rtf1\ansi\ansicpg1252\deff0\deflang1033{\fonttbl{\f0\fswiss\fcharset0 Arial;}} {\*\generator Msftedit 5.41.15.1515;}\viewkind4\uc1\pard\f0\fs20 The specific aims of this application are 1) to collect, process, and distribute human tissue samples\par from six institutions (Vanderbilt University Medical Center, St. Thomas Hospital, Meharry Medical College and\par Baptist Hospital in Nashville, TN, and Memorial Hospital in Chattanooga, TN, University of Louisville in\par Kentucky) to qualified researchers on a prospective basis; 2) to collect and bank pre-neoplastic lesions to\par facilitate basic research in tumor progression; 3) to provide macrodissection services; 4) to provide a\par DNA/RNA isolation service; 5) to perform quality control on all tissues harvested to ensure tissue quality and\par appropriateness; 6) to protect patient confidentiality by developing and implementing improved approaches\par to obtain explicit informed consent for use of extraneous tissue for research and through de-identification of\par specimens, or through anonymization of specimens if informed consent is waived; 7) to provide investigators\par with de-identified demographic and clinical data linked to samples, when appropriate consent has been\par obtained; 8) to develop an informatics platform for specimen tracking and for extraction and transmission of\par de-identified data relating to specimens of interest; 9) to develop and participate in marketing strategies for\par the CHTN.\par By including three private institutions and two additional academic institutions, a large number of\par specimens will be captured that would not otherwise be unavailable for research. The goal in the previous\par informatics strategy was to establish a secure, web-enabled format for networking of tissue procurement and\par requests. We have completed that task and the software product, TissueQuest, has been the sole shared\par networking module in use by the CHTN divisions since May 2007. We have now turned our attention to\par designing DonorQuest, our internal donor database.which will be scaleable and used across our participating\par institutions. It will be flexible enough to maintain compliance with changes in government regulations relating\par to use of human tissue in research. Finally, it is designed to accommodate new research technologies that\par demand more structured information to develop meaningful hypotheses from experiments with human\par tissues.\par Relevance: The goals of this application are highly relevant to furthering research in cancer and other\par diseases. By providing high quality well-annotated human tissue biospecimens in a cost-effective manner,\par CHTN-Western will facilitate research that will increase our knowledge of the pathobiology of human diseases\par and which may eventually have a significant impact on individual patient care and public health.\par \par }